Post-transcriptional regulation of germline mRNAs in C. elegans

Project Summary:
My lab is interested in defining how the maternal load is established during oogenesis and decoded
after fertilization. We know the identity of most important maternal transcripts and maternally supplied RNA-
binding proteins. We know that these factors are required for germline development, oocyte maturation, and
pattern formation in early embryogenesis. But we do not yet know which regulatory events are most important
for reproduction, or what mechanisms coordinate regulation in space and time.
We employed a “protein-centric” approach to map the wiring diagram of maternal RNA regulation in the
nematode Caenorhabidits elegans. We defined the sequence motifs recognized by a several maternal RNA-
binding proteins (RBPs) and identified of functional cis-regulatory elements in 3’UTR reporter genes
representing well studied maternal mRNAs. Our work made revealed that binding specificity is not sufficient to
explain mRNA targeting in vivo. All proteins studied to date bind to short linear partially degenerate motifs
present in at least 30-50% of all mRNAs. In some cases, the motifs have been shown to be necessary but not
sufficient to drive regulatory activity. In other cases, the motifs do not lead to regulation. Putting a motif, even in
multiple copies, into a transgene does not confer RBP-dependent regulation. Binding is not a great predictor of
regulation, revealing that binding site context is also crucial for targeting.
Moving forward, we are pursuing three major strategies. In the first, we are using CRISPR-cas9
genome editing to make mutations in the 3’UTRs of two critical maternal transcripts in order to identify which
regulatory events are most important to define the pattern of expression and for reproductive health. Genome
editing technology has advanced to the point where we can make targeted UTR deletions and substitutions, so
now we can assess importance directly. Our second direction is aimed at defining regulatory mechanisms. We
are performing AID-degron tagged experiments to define how RBPs and core regulatory machinery control the
maternal mRNA expression with temporal resolution in the germline and in the embryo. Finally, we wish to
understand how the biochemical properties of an RBP contribute to its mutant phenotypes. Proteins can have
multiple activities, and it is not always clear that the most obvious activity is the one that underlies its mutant
phenotypes. We are in position to address this question directly. We have expressed and purified several C.
elegans RBPs over the course of the past ten years and have begun to dissect their biochemical properties
using quantitative in vitro tools. We now have the ability to introduce mutations that effect RNA-binding
properties into the endogenous locus in C. elegans to determine phenotype.
Our innovative interdisciplinary approach, coupled to the strong atmosphere at UMass Medical School
in RNA biology and C. elegans genetics, will ensure rapid progress in defining the maternal effect in
embryogenesis at the functional level.

Public health relevance
Project Narrative: This project seeks to describe the basic principles that govern maternal RNA recognition and regulation in early development. Analysis of how post-transcriptional regulatory mechanisms, and more broadly how maternally supplied proteins and mRNAs, contribute to cell fate specification events in early development will ultimately lead to a better understanding of how developmental processes fail in disease. This project focuses on regulation mediated by the 3’UTR of maternal RNAs, and includes a variety of experiments to establish which regulatory events are most important for reproductive health, and how regulation works at a mechanistic level.